Opioid Use Disorder among Criminal Justice-Involved Women: Integrating Trauma-Informed and Gender-Specific Care with Medication-Assisted Treatment

Project Summary
Opioid-related overdose deaths and incarceration rates have skyrocketed and have
disproportionately affected women. Despite having a higher burden of substance use disorders
and HIV/AIDS than criminal justice-involved (CJI) men, CJI women are less likely to have
access to substance use and HIV treatment. The proposed intervention will link and retain
women with recent CJI in medication-assisted treatment (MAT) programs, identify and connect
women with necessary social services, and provide women with opioid overdose response
training. Specifically, the candidate aims to 1) conduct in-depth interviews with CJI women, MAT
providers, and criminal justice professionals to identify facilitators and barriers to illicit opioid use
cessation and decreases in HIV risk behaviors and exposure to violence among CJI women; 2)
develop a gender-specific and trauma-informed intervention that utilizes peer navigation to
connect CJI women with OUD to MAT programs, necessary health and social services, and
provides opioid overdose response training; and 3) conduct a pilot study (randomized control
trial) to assess the adequacy in which components of the gender-specific and trauma-informed
intervention function together using a sample of 50 community-recruited CJI women who use
opioids illicitly. In order to complete the proposed research tasks, the candidate has composed
a team of internationally recognized scholars as mentors. Through this proposed K01, the
candidate will expand the breadth of her work to treatment for opioid use disorders and common
comorbidities. The research and training outlined in this proposal will allow the candidate to gain
content expertise on social factors that lead to sub-optimal outcomes among CJI women with
OUD, trauma among substance-using and CJI women, while simultaneously developing her
skills in implementing and evaluating clinical trials. The candidate’s long-term career goal is to
develop evidence-based interventions to reduce substance use and its co-occurring health and
social consequences among marginalized and vulnerable communities. The proposed work
helps her make further strides to accomplishing this goal by enabling her to design, implement,
and evaluate a pilot intervention designed for CJI women.

Public health relevance
Project Narrative While the opioid epidemic and opioid-overdose related deaths have affected every demographic population, women, particularly criminal justice-involved (CJI) women, have been severely impacted. This proposal focuses on developing and implementing a gender-specific intervention that provides overdose response training and links and retains CJI women into medication- assisted treatment (MAT).